High-dose Testosterone in Men with Metastatic Castration-resistant Prostate Cancer and ATM or CDK12 deficiency

Abstract
Advanced prostate cancer is a universally lethal disease and one for which no biomarkers have yet been found
to inform therapeutic decision making. DNA repair deficiency in the homologous recombination and CDK12
pathways increases sensitivity of tumors to the DNA damaging effects of high dose testosterone based on
early biomarker interrogations of phase II high dose testosterone studies. High dose testosterone is also very
well tolerated in appropriately selected patient populations who are asymptomatic. The proposed study is a
two arm phase II study of high dose testosterone in men with metastatic, castration resistant prostate cancer
containing mutations in ATM or CDK12. Patients would receive intermittent high dose testosterone
(intramuscular injections Day 1 of each monthly cycle) until clinical or radiographic progression or intolerance.
Androgen deprivation is continued in order to maintain consistent nadir testosterone levels which are critical to
the concept of inducing genomic instability by exposing tumor cells to very high and low testosterone levels
over the length of the cycle. The primary endpoint will be 50% decline in PSA from baseline. Secondary
endpoints are radiographic response per RECIST, radiographic progression free survival, PSA progression
free survival, overall survival, PSA50 response rate in each genomic subgroup, quality of life by FACT-P and
International Index of Erectile Function (IIEF) surveys and incidence and severity of adverse events according
to CTCAE version 4.0. This study will provide critical information regarding efficacy and toxicity of high dose
testosterone therapy in a biomarker selected population. High dose testosterone in appropriately selected
patients is very well tolerated and would provide treatment options for patients who are otherwise not at the
appropriate point in their treatment sequence for other treatments. The importance of this study will be to
establish the utility of DNA repair deficiency in specific genes as a predictive biomarker for response to high
dose testosterone and to justify larger studies targeting specific subsets, particularly for subsets for which
effective therapies have not yet been established such as ATM and CDK12.

Public health relevance
Relevance Prostate cancer is the leading cause of cancer related death in veterans. Although significant progress has been made in treatment, “exceptional responses” are rare and there is currently no way to personalize care for the majority of men with this disease. This study will test the effectiveness of high dose testosterone, a drug with early evidence for responses across a range of genes involved in DNA repair and with excellent tolerance in patients with ATM or CDK12 inactivating alterations in their prostate cancers. If successful, this study could provide a means of predicting which veterans could benefit from more effective and less toxic therapy for metastatic, resistant prostate cancer.